ELECTRON SPIN RELAXATION OF 5 DOXYLSTEARIC ACID SPIN LABELS &L1210 CELLS

Experiments were conducted in an attempt to measure the electron spin-relaxation time (T1) as a function of oxygen concentration in the spin label 5-doxylstearic acid in respiring and non-respiring cells. It was possible to obtain results only for the non-respiring cell systems.